BREATHE WELL: Development and Implementation of a Training Program to Increase Vaccination in Early Childcare and Education Centers

PROJECT SUMMARY / ABSTRACT
Early childcare and education (ECE) centers are trusted institutions that engage with parents regularly,
positioning them as key messengers for childhood immunization and respiratory health promotion. While ECE
centers ensure compliance with mandated vaccines, their potential to support uptake of non-mandated
immunizations—such as influenza vaccine, COVID-19 vaccine, maternal RSV vaccine, and nirsevimab
antibody—remains underutilized. The BREATHE Well (Building Readiness, Engagement, and Trust for Healthy
Environments) Toolkit is an evidence-based intervention designed to enhance ECE-originating vaccine
communication, training ECE staff to effectively engage parents on immunization topics. This study will
evaluate the feasibility, acceptability, and effectiveness of the BREATHE Well toolkit using a cluster-
randomized controlled trial (RCT). The project will be guided by three specific aims: (1) Develop and refine the
BREATHE Well toolkit through formative research, incorporating input from ECE staff, parents, and public
health officials; (2) Assess the acceptability and feasibility of the toolkit through focus groups and surveys with
ECE staff and parents in demonstration sites within Michigan; and (3) Evaluate the effectiveness of the toolkit
in a cluster-randomized trial of ECE centers, measuring changes in parental vaccine confidence, intent to
vaccinate, and staff capacity to serve as trusted messengers. The BREATHE Well toolkit will be designed as a
scalable approach usable in different types of ECEs. Findings from this study will inform best practices for
integrating vaccine-related education into ECE settings, with the goal of increasing parental vaccine confidence
and improving uptake of recommended immunizations.

Public health relevance
PROJECT NARRATIVE This study will evaluate the BREATHE Well Toolkit, an ECE-based intervention designed to train childcare staff as trusted messengers for vaccine-related communication. Using a cluster-randomized controlled trial, we will assess its feasibility, acceptability, and impact on parental vaccine confidence and uptake. Findings will inform scalable public health strategies to improve immunization education towards parents of young children.